Elucidating the Cellular and Molecular Mechanisms of IgE Catabolism

PROJECT SUMMARY/ABSTRACT
The increasing prevalence of both food and airway allergy in the last half-century is indicative of a critical need
to understand the underlying biology and develop effective treatments. Crosslinking of the antibody isotype IgE
on mast cells and basophils is directly responsible for allergic symptoms, signifying a critical role for IgE in the
pathophysiology of allergy. Allergen-specific IgE and the corresponding allergies can persist for a lifetime.
However, the mechanisms that govern the catabolism of IgE and distinguish it from other antibody isotypes,
such as IgG, remain poorly understood. This research project seeks to uncover the cellular and molecular
factors responsible for IgE catabolism. Regulation of IgG half-life is of interest for both improving current
monoclonal therapeutics and treating autoimmunity; targeting IgE in a similar fashion could allow for specific
control of pathogenic IgE. A striking finding from this proposal using transgenic mice is that the two canonical
receptors for IgE, FcεRI and FcεRII, are dispensable for controlling the half-life of IgE in circulation, which is
much shorter than that of IgG. IgE is primarily observed in a cell-bound state, which contrasts with the
predominance of IgG in soluble form. IgE also possesses unique sugar modifications known as glycans, which
affects its cognate receptors. Preliminary data generated by the applicant shows IgE bound to the surface of
macrophages of the spleen and liver. As such, this proposal hypothesizes that IgE is recognized by novel
receptors on macrophages in a glycan-dependent manner. The experiments of Aim 1 seek to investigate the
receptors and cell types directly responsible for IgE catabolism through high-throughput yeast display, single-
cell RNA sequencing (scRNA-seq), and radioactive tracing. In particular, the role of spleen and liver-resident
phagocytes in this process will be studied using transgenic mouse models. Aim 2 of the proposal focuses on
characterizing the impact of IgE glycosylation on catabolism. The effect of IgE oligomannose modifications on
its binding to receptors and its clearance kinetics will be evaluated using flow cytometry and fluorescence
kinetics. Furthermore, quantitative polymerase chain reaction (qPCR) analyses will be used to investigate the
regulation of IgE plasma cell enzymatic machinery on glycosylation. Collectively, these data will uncover key
components of the signaling networks controlling IgE catabolism. In particular, the identification of a novel
receptor could lead to the development of new therapeutics targeting pathogenic IgE. The applicant’s team of
mentors has a diverse set of expertise that will facilitate the success of the project and the applicant’s
development into an independent researcher in Type II inflammation.

Public health relevance
PROJECT NARRATIVE Allergies have dramatically increased in developed countries in the last several decades and can lead to deadly reactions. These responses are driven by IgE, an antibody isotype whose fundamental biology is poorly understood. By elucidating the molecular and cellular mechanisms of IgE clearance, this project will provide insights into the persistence of allergy and highlight potential therapeutic targets.